The MARC Program at UCSC

PROJECT SUMMARY
The primary goal of the MARC program at UC Santa Cruz is to recruit and prepare underrepresented
(UR) students for entry into biomedical PhD programs. This is initially achieved by increasing the rate at
which UR undergraduates become involved in cutting-edge research at our institution. An important
component of our MARC program is to create a larger community of UR and first-generation-in-college
students who identify as biomedical researchers and who help promote each other towards PhD-level
graduate training. Until this year, this community at UCSC included the 14 MARC scholars and the 23
undergraduates supported by the IMSD program. As the IMSD undergraduate program has ceased and
IMSD graduate training transitioned to a T32 program, we are requesting a total of 26 slots for the MARC
program to allow us to maintain the core of this larger community of undergraduate STEM Diversity
scientists. The aims of this training program proposal are to:
1 - develop a program for a larger MARC cohort of 26 students that fuses the strongest
components of our current MARC and IMSD programs. This program will incorporate recruitment,
rigorous laboratory training, placement with faculty, and professional development. The challenges will
be in how to scale up from the current 14 MARC trainees, however there are important lessons from the
success of our IMSD program. The director of that program, Prof. Melissa Jurica, has joined MARC as
co-PD so that best practices that she developed working with the larger IMSD undergraduate cohort can
be incorporated.
2 - ensure that 100% of graduating MARC fellows develop strong independent research skills.
We are approaching this challenge from two perspectives. First, we will develop a team approach to
ensure adequate measurable progress in student development of research independence. Second, we
will launch a program to have all students write an NSF Graduate Research Fellowship (GRFP)
application so that they can learn the skills of experimental design and grantsmanship.
3 - ensure that 100% of MARC fellows who are admitted into PhD programs are capable of
persisting through to completion. We are developing a program to prepare students for the new types
of social and professional challenges they will face in graduate school. MARC students will make contact
with our alumni mentor network and from them learn the social and professional challenges to anticipate
in their new environment. The members of the MARC fellow's mentoring team and alumni network will
remain available after graduation to provide them with personalized mentoring and coaching as needed.

Public health relevance
RELEVANCE Bringing people from different cultures with diverse life experiences to the research endeavor is an important advantage for our country in developing and maintaining innovation in cutting-edge research science. The primary goal of the project is to prepare undergraduate students from underrepresented groups and those who are the first in their family to attend college for entry into doctoral programs leading to research careers in the biomedical sciences. MARC trainees perform important research to advance our understanding of the mechanisms of life.